Discovery of new therapies for anorexia nervosa using using human dopaminergic neurons derived from AN patient iPSCs

Project highlights: differentiation protocols from iPSC to dopaminergic neurons developed by Dr. Raos lab at NIH. Developing 384-well dopamine uptake assays at NCATS. During this period, the NCGC has fostered and maintained over 180 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to over 100 high-throughput screens and nearly 60 medicinal chemistry campaigns, providing our collaborators and the general research community a wealth of publications and promising small molecule leads. In addition, the NCGC has undertaken a number of informatic challenges to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.